The Neural Circuit Basis of Olfactory Navigation in Adult Drosophila

PROJECT SUMMARY
In order to forage effectively for food, the brain must integrate innate and learned information about the
value of different food odors and use this information to select navigational motor programs. Although a
great deal is known about how the brain computes the value of odor stimuli, how it uses this information
to guide navigation remains mysterious. Here we propose to investigate the role of a conserved
navigation center, the fan-shaped body (FB), in olfactory navigation. The FB receives a large number of
inputs that are anatomically downstream of innate and learned olfactory processing centers. We have
identified several lines labeling such inputs that respond to attractive odor and drive upwind orientation
when activated. Here we will use whole-cell electrophysiology and imaging to investigate the
representation of innate and learned odor value signals in FB input neurons. By combining these
functional data with detailed connectomic information, we will generate quantitative models that relate
sensory representations to anatomical connectivity. Next we will use both synchronous and asynchronous
recordings to measure and model the relationship between FB neuron activity and navigational action
selection. Finally, we will develop a new optogenetic plume assay that will allow us to determine the role
of FB neurons in different aspects of odor plume navigation. Together these experiments and models will
generate testable predictions about how the organization of central navigation circuits supports a critical
goal-directed behavior, odor-guided food search.

Public health relevance
PROJECT NARRATIVE How the brain uses odor cues to find food is not well understood. In this project we will investigate the function of an ancient navigation center called the fan-shaped body in transforming odor cues into navigational movements. This project will help us understand how brain circuits are organized to allow for goal-directed movements.